Sodium Channel Dysfunction in Altered Brain Development

Project Summary
Ion channel dysfunction is a leading cause of malformations in cortical development (MCDs), resulting in severe
neurological disorders and disability. In particular, findings from our group and others have indicated a crucial
role for sodium channel subtypes and ion transporters in early human brain development, suggesting that ion
channel diseases affecting children likely have prenatal pathology prior to diagnosis after birth. Importantly,
several pathogenic variants of the voltage-gated sodium channel subtypes SCN2A and SCN3A produce
complex, non-overlapping phenotypes of abnormal brain development. For example, we found severe gain-of-
function (GoF) SCN2A variants associated with MCDs and seizures, in contrast to other GoF SCN2A variants
associated with developmental and epileptic encephalopathy. These distinct SCN2A variant phenotypes lead us
to hypothesize that the level of GoF sodium influx could result in dose dependent effects at different stage of
perinatal development. To investigate cellular and biophysical SCN2A pathologies during prenatal development,
we established transient transgenic ferrets as a validated system to phenocopy human MCDs. Unlike mice,
ferrets possess a human-like neocortex with developmental cell types and brain folds (gyri and sulci) critical for
cognitive function. Utilizing transient transgenic ferrets, we propose to examine novel SCN2A variants associated
with severe neurodevelopmental disease to define the prenatal (Aim 1) and postnatal (Aim 2) onset and biological
basis for SCN2A-associated disorders. Establishing the early pathological origins of SCN2A-associated
diseases (e.g. effects on proliferation, cell fate, migration, and action potential kinetics) is necessary for
developing treatments that intervene prior to irreversible brain changes. In addition, this work will provide a critical
window to examine fundamental processes of cortex development regulated in utero by sodium channel activity.

Public health relevance
Project Narrative Ion channel dysfunction is a leading cause of malformations in cortical development, resulting in a broad array of severe neurological disorders in children and imposing a heavy burden on individuals, families, and society. While human genetics studies have associated the ion channel SCN2A with severe neurodevelopmental diseases, there remains a serious unmet public health need to understand the onset of disease pathophysiology before irreversible brain damage occurs. In this proposal, we will investigate the biological basis of the most severe SCN2A-associated phenotypes in children — malformation of cortical development with epilepsy — with the goal of translating these mechanistic findings to guide treatment interventions and therapeutics.